Early Career-CeNtered EnricHment to AdvaNce Research Careers in Maternal HEalth -ENHANCE-M

Project Summary/Abstract
Improvements in equitable maternal health will require rigorous research methods and the inclusion of pregnant
and lactating people in clinical trials. Early Career-CeNtered EnricHment to AdvaNce Research Careers in
Maternal HEalth (ENHANCE-M) will identify and train a diverse group of postdoctoral fellows and early-stage
investigators with a commitment to a career in maternal health research. Trainees will be recruited from the
Medical College of Wisconsin and partnering institutions that have diverse pool of candidates from
underrepresented groups in biomedical research workforce. The curriculum will be grounded in clinical
research methodologies and community engagement. Practices will include hands-on, team-based learning,
leveraging MCW U54 research projects with a focus on clinical trials design and management, structural
racism and SDOH that affect maternal morbidity and mortality, recruitment of diverse participants, thriving and
resilience in academia, grant writing, and mentor engagement and networking. Our overarching goals are to
train a diverse group of postdoctoral fellows and early-stage investigators in community engaged research and
in clinical trials involving birthing people. The specific aims of the training program are: Aim 1: Recruit
postdoctoral fellows and ESI from racially and ethnically diverse backgrounds to participate in a 24-month
maternal health clinical research program focused on community engaged research and clinical trials. Aim 2:
Implement and evaluate the 24-month maternal health clinical research program. Intermediate benchmarks
of success include creation of and adherence to an individualized development plan (IDP) and set expectations
for numbers of presentations, publications, and grant applications each year. Long-term benchmarks for
success include for at least 30% of our postdocs to remain in research-related career within 3 to 5 years of
exiting the program, and for at least 30% of our ESI faculty to obtain extramural funding.